Indiana University: Training in Behavioral Nursing

DESCRIPTION: The aim of this research training program is to build the knowledge base about health behavior that (a) promotes maximal well-being; (b) facilitates early detection of disorder to minimize its effect, and (c) facilitates quality of life in illness situations. To accomplish this long-term objective, research training is provided annually to three predoctoral and three postdoctoral trainees that encourages the following skills: (a) analysis of concepts and theories from the behavioral and biological sciences that have relevance to health behavior change; (b) synthesis of concepts, theories and research findings from the behavioral and biological sciences to frame research concerned with health behavior problems/challenges; (c) design and conduct of research for the purpose of advancing knowledge about health behavior; (d) dissemination of findings in a timely manner; and (e) development of resources in support of health behavior research. To provide trainees with such an experience, Indiana University School of Nursing must: (a) provide a research-intensive environment, with an expanding portfolio of health behavior research; (b) build a quality research training program; (c) provide accomplished interdisciplinary research advisors; and (d) recruit qualified trainees. Research training includes a Health Behavior Journal Club, Behavioral Intervention Workshops, placement on interdisciplinary research teams and similar intensive mentoring experiences. In addition to course work as appropriate. Predoctoral trainees are supported for 2-3 years, and expected to apply for individual NRSA funding; postdoctoral trainees are supported for 2-3 years and expected to complete at least one grant application for external funding. Trainees have access to the four research programs embedded within the School of Nursing--the WHO Collaborating Center for Healthy Cities, the Mary Margaret Walther Program for Cancer Care Research, the Behavioral Cooperative Oncology Group, and the Center for Enhancing Quality of Life in Chronic Illness--, in addition to dozens of other research centers at Indiana University. Trainees also have access to Clarian Health Partners, the second largest hospital network in the United States, as well as scores of other clinical/community agencies.